Establishing an Artificially Intelligent Framework for Improving Therapeutic Alliance with Obese African American Youth and Caregivers through Multimodal Monitoring of Empathetic Accuracy and Interper

PROJECT SUMMARY/ABSTRACT. Obesity is a significant public health concern among all racial/ethnic groups, ages, gender, and geographic areas, but some groups are more disproportionately affected than others. Ethnic minority adolescents, especially AAs, are disproportionately likely to be obese relative to non-Hispanic White adolescents.29,30 The proposed study is designed to improve a comprehensive multicomponent family-based behavioral intervention (FIT Families) delivered by Community Health Workers (CHWs; therapists) for African American (AA) adolescents with obesity (AAAO). This application expands a program of research that has followed the Obesity Related Behavioral Intervention Trials (ORBIT) for developing behavioral treatments,31 by capitalizing on our recent work using innovative machine-learning (ML) models to thoroughly examine within-session therapy processes (i.e., mechanisms of action), specifically the role of CHW empathy in the development and maintenance of the therapeutic alliance (TA) while treating AAAO and their primary caregivers. TA is considered an essential element of therapy.32 The TA is composed of three features: 1. Emotional bond between therapist and client; 2. Agreement between the client and therapist on the goals of treatment; and 3. Agreement on the tasks of therapy.33 TA is a dynamic, bidirectional, and synergistic element of therapy with implications across differences in race, age, and gender of the client and therapist. Therapist empathy is critical in establishing and maintaining a strong TA, with outcomes mediated by the therapeutic alliance. Empathy accounts for more variance in therapy outcome than specific interventions34 and consistently predicts client change.35 Unfortunately, analysis of crucial facilitative interpersonal skills such as therapist empathy is technically challenging as the intent of another’s behavior is nuanced, contextual (e.g., therapists and client differ in personality, background, cultural values, etc.), and interactive (bidirectional and synergistic); and can be expressed in multiple ways (voice tone, physiology]). To better understand empathy, requires empirical approaches and analytical tools that can discern empathetic behaviors in actual clinical encounters that produce behavior change. We will operationalize empathy through two measures that are each associated with empathy and treatment outcomes: 1) Empathic accuracy, defined as the CHW’s accurate understanding of the client’s state; and 2) Interpersonal physiological synchrony (IPS), defined as the correlation between therapist and client IPS over time (i.e., heart rate [HR], HR variability, galvanic skin response, voice features). This study uses these two empathy measures to understand the relationship between empathy, therapeutic alliance, and treatment outcomes. Further, the study will explore how empathy effects change based on the race and gender concordance/discordance of therapist-client dyads. Toward future clinical translation, the audio and physiological data collected will be used to build a M-L classification model for differing degrees of empathy. This model could then be used to provide real-time feedback for therapists training to improve their empathic responses.

Public health relevance
Recent advancements in wearable and wireless technologies, multivariate time-series analyses, and artificial intelligence has allowed scientists to further explore the predictive validity of therapy processes (therapeutic alliance, therapist empathy) to treatment outcome, and extend the assessment of these processes within and across sessions, and especially, in the treatment of health disparate populations. The proposed study aims to use wearable biosensors, natural language processing, and innovative machine-learning (ML) models to more thoroughly examine within-session therapy processes and interpersonal synchrony, specially the role of therapist accurate empathy in the development and maintenance of the therapeutic alliance in the treatment of obese African American adolescents and their primary caregivers. The results of the study will provide much needed information on the dynamic and mutually influential dyadic interpersonal relationship between therapist and clients.